Precision medicine approaches to understand and prevent stillbirth

ABSTRACT
Stillbirth (i.e., fetal demise after 20 weeks’ gestation) is a common and devastating adverse pregnancy outcome
that affects 1 in 160 pregnancies (~23,600 pregnancies in the US each year) and has lifelong medical and
psychosocial impacts for affected individuals and their families. Rates of stillbirth are alarmingly disparate among
US populations—non-Hispanic Black, American Indian/Alaskan Native, and Pacific Islander-identifying
individuals have a 2-fold higher stillbirth rate compared to other racial groups. Available data does not explain
the basis for these disparities and lacks fundamental social determinants of health (SDOH) information. While
placental pathology, fetal autopsy, and genetic testing are the highest yield tests for determining the cause of
fetal demise, many patients do not have a complete workup due to patient, provider, and systems-level issues.
Finally, despite advances in non-invasive technologies to assess placental function and overall pregnancy health
across gestation, the mechanisms underlying placental dysfunction at the maternal-fetal interface remain poorly
understood, stillbirth remains difficult to predict, and preventative measures are limited. Multi-disciplinary
interventions at all levels are urgently needed to address stillbirth outcomes. In recognition of this urgent need,
the NIH-NICHD released the NOSI, “The Road to Prevention of Stillbirth” to support transdisciplinary stillbirth
research efforts. In response to this NOSI, we leverage the international infrastructure of the Fetal Genomics
Consortium (FCG) and the local infrastructure of the University of Washington Pregnancy Biorepository (WPR)
to launch a multi-faceted initiative to: improve clinical evaluation and data collection for stillbirth, advance tools
to evaluate maternal-fetal interface immune biology and detect placenta dysfunction, and develop novel models
to predict an individual’s risk of stillbirth. Specifically, we aim to: (1) standardize clinical evaluation, genetic
testing, and data collection from patients with stillbirth by implementing a Stillbirth Evaluation Pathway across
the University of Washington (UW) hospital network; (2) delineate maternal-fetal interface genomic and immune
signatures associated with placental dysfunction and stillbirth using paired maternal-fetal whole genome
sequencing data, cell-free DNA/RNA metrics, and placental immune signatures; and (3) develop a personalized,
high-fidelity tool using machine learning approaches to predict the risk for stillbirth in pregnant individuals
longitudinally. Taken together, these aims will facilitate a precision medicine approach for stillbirth and advance
equity in care. The rich dataset of integrated clinical, SDOH, and genomic information harmonized within the
larger infrastructure of the FGC network will create an invaluable tool for the research community for future
investigations. Ultimately, these insights will enable the development of novel interventions, therapeutics, and
prevention strategies with the potential to dramatically improve reproductive health.

Public health relevance
PROJECT NARRATIVE Stillbirth is a common and devastating pregnancy outcome affecting 1 in 160 pregnancies; many stillbirths remain unexplained. Here we propose to standardize data collection and improve clinical and genetic workup of stillbirth, identify biologic pathways involved in stillbirth, and develop machine learning tools to predict stillbirth more accurately. As stillbirth is an urgent maternal health crisis impacting >23,000 pregnant individuals annually in the United States with marked disparities, understanding the underlying causes and creating tools to predict risk would have a dramatic impact on public health.